Inflammatory Resolution and Vascular Restoration in Diabetic Retinopathy

Title: Inflammatory Resolution and Vascular Restoration in Diabetic Retinopathy
ABSTRACT
Diabetic retinopathy (DR) remains a leading cause of blindness in the United States. Recent clinical trials
reveal targeting vascular endothelial growth factor (anti-VEGF) for diabetic macular edema (DME) reduces
edema and improves vision in about half of treated patients. However, alternative treatment is needed for the
large number of patients who do not respond to anti-VEGF therapies. The current application presents a novel
approach to understand disease pathology and apply preclinical testing to a potential treatment for DR. Our
novel hypothesis is that diabetes impairs the retina's reparative mechanisms, and that this contributes to the
accumulation of unrepaired damage in the diabetic retina. In this proposal we will explore how diabetes impairs
the retina's ability to resolve inflammation and to restore the inner blood-retinal barrier (iBRB) after injury. This
is analogous to the deficiency in skin wound healing that results in non-healing diabetic foot ulcers. Although
recent studies have begun to shed light on formation of the iBRB during eye development, little is known about
the mechanisms governing maintenance and restoration of the iBRB in the adult. This represents a major
knowledge gap that is highly relevant to DR prevention and treatment since restoring the iBRB is precisely
what we strive to achieve for treatment of DME. The transformative approach is to use a retinal injury, in much
the same way that skin laceration is used to study the effects of diabetes on wound healing, with the goal of
overcoming diabetes induced inhibition of repair and promoting retinal restoration. These studies therefore
utilize the mouse retinal ischemia-reperfusion (IR) injury model to examine the effects of diabetes on
mechanisms governing restoration of the iBRB. IR injury mimics several characteristics of DR pathology,
including: inner retina neuron loss, microglial activation, leukostasis, barrier tight junction disorganization, and
vascular permeability. We believe that IR is the optimal choice of retinal injury to study the effects of diabetes
on reparative mechanisms because IR is the only retinal injury model that includes self-resolving inflammation
and extended vascular permeability followed by restoration of the iBRB. Preliminary data shows that
restoration of the iBRB after IR injury normally occurs over 2-3 weeks but is defective in diabetic mice, and this
coincides with amplification of innate immune responses. To determine how diabetes impedes inflammatory
resolution and retinal vascular restoration, we will complete three Specific Aims: 1: Understand the process
of vascular barrier restoration. 2. Identify the mechanism by which diabetes impedes restoration of the
iBRB. 3. Target atypical PKC-mediated inflammation to promote barrier restoration. The research efforts
represent a close collaboration between the Abcouwer and Antonetti laboratories expert in retinal inflammation
and the blood retinal barrier, respectively. The research is expected to provide novel insight into mechanisms
of iBRB restoration and provide additional therapeutic options to promote this process in patients.

Public health relevance
PROJECT NARRATIVE The current research proposal explores mechanisms by which diabetes impairs the retina's ability to resolve inflammation and to restore the vascular barrier, thus leading to diabetic macular edema. The project applies a novel approach that uses an injury to reveal how diabetes impairs the retina's ability to repair the barrier and prevent leakage of molecules that cause swelling and loss of vision. This new paradigm is also used for pre-clinical testing of a novel class of drugs that show promise for promoting resolution of retinal inflammation and restoration of the vascular barrier, so as to provide treatment options for diabetic retinopathy patients that do not respond to current treatments.